Mechanisms of Integrative and Conjugative Elements in Oral Bacteria

Project Summary
Streptococcus mutans resides in the oral cavity where it is known to initiate the development of dental caries.
For this pathogen to thrive in the dynamic and variable environment of the mouth, S. mutans must be able to
adapt to both short- and long-term ecological pressures. The horizontal acquisition of new DNA, which may
encode for new beneficial traits, is a critical aspect of S. mutans adaptability. In addition, regulation of the
processes involved in the acquisition of DNA are intertwined with the basic physiology and stress responses of
S. mutans. Mobile genetic elements often mediate HGT and include integrative and conjugative elements
(ICEs), widespread among oral bacteria. ICEs are mobile elements that are integrated on the genome and
possess the ability to excise and subsequently transfer to nearby bacteria via conjugation. Importantly, these
elements often contain “cargo” genes that provide some benefit to the host bacterial cells (including antibiotic
resistance, metabolism, and virulence). In recent work supported by R03 DE029882 and F32 DE032551, we
undertook the first characterization of TnSmu1 as a model of HGT within this critical oral pathogen. We
discovered that TnSmu1 is a functional ICE, capable of transfer. Further, we have made significant progress
investigating a regulatory system that controls activation of TnSmu1 and showed that TnSmu1 causes a host
cell defect in cell division. Further, when TnSmu1 excision is induced, the S. mutans Type I-C CRISPR-Cas
system is up-regulated, for reasons that are currently unclear but possibly suggesting an interaction between
TnSmu1 and this bacterial defense mechanism. Together, this indicates TnSmu1 shares a complex
relationship with its host bacterial cell.
Despite the prevalence of ICEs in oral bacteria and the significant impact of TnSmu1 on host cell
physiology, detailed studies of their molecular mechanisms and their impact on oral communities are lacking.
To address this, we propose to use TnSmu1 as a model of conjugal transfer in the following Specific Aims:
Aim 1: Dissect the regulatory mechanisms that control the switch from the integrated to excised state of
TnSmu1. Aim 2: Elucidating interactions of TnSmu1, mobile genetic elements, and CRISPR-Cas defense in
bacterial hosts. Aim 3: Investigating the fitness cost(s) of TnSmu1 acquisition on recipient strains. Taken
together, these studies will provide a wealth of information for an understudied mechanism of gene transfer in
the oral microbiome. Elucidating mechanisms of gene transfer is critical for understanding of S. mutans
adaptability and the ability to combat oral disease. At the conclusion of these studies, this work will have
created a new understanding of HGT, evolution, and pathogenesis of S. mutans within the oral microbiome.

Public health relevance
Project Narrative Horizontal gene transfer through mobile genetic elements drives the adaptive evolution of bacterial pathogens and contributes significantly to the spread of pathogenic properties throughout bacterial communities. We recently discovered an integrative and conjugative element (a type of mobile element that is transferred from cell to cell via conjugation) on the genome of the oral pathogen Streptococcus mutans. In this project, we will investigate fundamental aspects of the element’s biology and its influence on S. mutans pathogenesis, including the signals that govern this transfer, interactions with other mobile genetic elements and bacterial defense systems, and elemental mechanisms that may ultimately harm the host bacterial cell.